Development of amyloid conformer-targeting technologies in type 2 diabetes mellitus

PROJECT SUMMARY
Type 2 diabetes mellitus (T2DM) represents a significant and escalating global health crisis, with a profound impact on
millions of lives and healthcare systems worldwide. Central to the pathogenesis of T2DM is the deposition of islet amyloid
polypeptide (IAPP) aggregates, which are implicated in the dysfunction and loss of pancreatic β-cells, leading to the
progressive failure of insulin production. Despite the critical role of amyloid aggregation in T2DM and its complications,
therapeutic strategies targeting this process remain underexplored and represent a substantial unmet medical need. The
founders of Aggregate Biosciences have developed an innovative platform technology for discovering conformation-
specific, anti-protofibril monoclonal antibodies (mAbs) that target intermediate amyloid aggregates. Resulting mAbs have
shown the ability to target and clear hIAPP aggregates in vivo, leading to improved biomarkers in a mouse model of
amyloid-induced diabetes. Building on this innovative approach, we hypothesize that removing toxic hIAPP protofibrils in
prediabetic or early diabetic patients could significantly improve β-cell health and delay T2DM progression. However, given
the recent lackluster results from FDA-approved therapeutics targeting soluble amyloid intermediates, we hypothesize that
specific amyloid conformers are the predominant strains driving disease pathogenesis. Our platform offers a unique
opportunity to isolate these amyloid conformers and discover conformation-specific mAbs targeting these conformer strain
groups. By employing our lead pan-conformer chaperone-like amyloid modulating protein (CLAMP), nucleobindin-1
(NUCB1), we aim to develop a novel conformer-specific mAb screening platform and an optimized NUCB1-
immunoglobulin fusion protein (NUCBody) for targeting a wide range of amyloid conformers. The successful development
of this platform and subsequent proof-of-concept studies detecting 'conformer space' in disease could introduce a
groundbreaking approach for categorizing amyloid strains, potentially leading to revolutionary diagnostic strategies and
therapeutics. By focusing on the identification of disease-specific amyloid conformers, this project addresses a critical gap
in current research and treatment methodologies, with the potential to revolutionize the management and treatment of
T2DM and other amyloid-related disorders.

Public health relevance
PROJECT NARRATIVE Prediabetic patients, characterized by impaired glucose tolerance and insulin resistance, are at an increased risk of developing type 2 diabetes and may exhibit elevated serum amyloid levels, indicative of early pathological changes associated with amyloid aggregation. Our innovative technology is hypothesized to not only detect amyloid aggregates in serum with high sensitivity and specificity but also to facilitate their clearance, offering a dual-action approach to mitigating amyloid-associated pathologies. The successful development and implementation of this technology could revolutionize the early detection and treatment of amyloid-related diseases, potentially delaying or preventing the onset of type 2 diabetes and other amyloidosis disorders, thereby improving patient outcomes and reducing healthcare burdens.